The role of indoleamine 2-3 dioxygenase in marginal zone-mediated tolerance

The spleen is important for removing cellular debris. Central to this function are a specialized set of macrophages that recognize and capture particulate matter from circulation. In Systemic Lupus Erythematosus it is suggested that defective function of macrophages to clear dear cells promotes disease development and progression. However, how this occurs on a functional level is unknown. To examine this we removed macrophages from the spleen of mice that spontaneously develop lupus-like disease and found this greatly increased autoimmunity in the animals signifying splenic macrophages play an important role in preventing systemic autoimmunity. We subsequently found that dead cells induce expression of an enzyme that degrades the essential amino acid tryptophan and is important immune tolerance. Further we found blockade of this enzyme, indoleamine 2-3 dioxygenase, greatly altered the way macrophages respond to dead cells and lead to increased autoimmune disease activity in lupus-prone animals. The data strongly indicate that this activity may be important in the prevention immune responses to self-determinants in a novel regulatory mechanism. Our project will examine how dead cells induce indoleamine 2-3 dioxygenase expression, how expression of the enzyme impacts behavior of macrophages, and if we can manipulate the suppressive activity of indoleamine 2-3 dioxygenase for therapeutic purposes. The findings of this project could have enormous implications in our treatment of chronic inflammatory disease providing greater understanding of the basic biology as well as new therapeutic targets.

Public health relevance
Systemic Lupus Erythematosus is caused by multiple factors including chronic inflammatory responses to cellular debris within the body. Our project will characterize regulatory pathways which may be vitally important in the prevention of inflammation to cell debris providing insight into inflammation regulatory processes as well as new potential targets for the treatment of autoimmune disorders.